Stimulation of novel spinal respiratory circuit to restore breathing in ventilator-dependent patients with SCI.

PROJECT SUMMARY/ABSTRACT
Respiratory failure after spinal cord injury (SCI) impairs the health of the injured patients, and respiratory failure
is the leading cause of death in patients with SCI. Treatment of respiratory failure consists of mechanical
ventilation, in which a mechanical pump is used to facilitate air exchange with the lungs. Mechanical ventilation
is invasive, costly, limiting, and carries with it a high risk of complications and death. Mechanical ventilation
provides an unvarying pattern of ventilation that is not responsive to physiological demands; it does not
recapitulate normal breathing. Normal breathing is a complex behavior under both voluntary and involuntary
neural control; it is responsive (in milliseconds or less) to the physiological state of the patient. Restoration of
fully integrated, naturalistic breathing would represent a significant advance in the treatment of respiratory failure
following SCI. The main hurdle to accessing the neural network for breathing for therapeutic purposes is that the
neural mechanisms controlling respiration reside deep in the brainstem, which is dangerous to access surgically.
Recently, we elucidated a novel breathing pathway in the spinal cord that can be modulated by electrical
stimulation of the cervical spine, an area that is surgically accessible. We have compiled significant data that
stimulating the cervical spine can restore or augment breathing. Clinically approved epidural spinal cord
stimulators exist to treat pain, and these stimulators can also be used to stimulate the cervical spine to restore
respiratory function. The main objective of this project is to provide proof of the concept that cervical epidural
stimulation can improve respiratory function in ventilator-dependent patients with SCI and define the stimulation
parameters that most effectively restore more normal breathing. The deliverables for this 5-year project include
establishing the safety and feasibility of epidural stimulation for respiratory rehabilitation in SCI and providing an
algorithm to select the optimum stimulation variables to augment respiratory activity in each patient (e.g.,
stimulation site, dose, and timing). If successful, we anticipate using epidural stimulation to partially or completely
wean each patient with SCI off mechanical ventilation, which would have immediate benefits — increased
independence, improved quality of life, and decreased costs and risks associated with mechanical ventilation.
Conventional thinking is that once the spinal cord is injured, little or no functional recovery is possible. This dire
sense of irrreversibility is at odds with our research in spinal cord neuromodulation, which has shown that
substantial recovery of voluntary hand and upper extremity function can result from epidural spinal cord
stimulation. A similar neurmodulatory strategy may be used to augment or restore respiratory function in patients
with SCI. If successful, this neuromodulatory strategy to restore respiratory function may usher in a new era of
respiratory neurorehabiltitation for SCI, and potentially other neurological disorders, and transform our
understanding of neural circuits governing respiration and the plasticity of injured states of the spine.

Public health relevance
PROJECT NARRATIVE Respiratory failure due to neurological conditions, such as spinal cord injury, is treated with mechanical ventilation, which may result in significant mortality and morbidity. Our previous studies demonstrated that epidural stimulation can be used to control the excitability of localized neural circuits in the cervical spine such that respiratory function can be modulated and enhanced. The proposed studies will investigate the safety and feasibility of using high-density epidural stimulation to target the cervical respiratory circuit and restore respiratory function in patients with spinal cord injury.